Small Animal Imaging Facility Shared Resource

PROJECT SUMMARY/ABSTRACT
Operating under the University of Wisconsin Carbone Cancer Center (UWCCC), the Small Animal Imaging
Facility (SAIF) provides innovative, cost effective, high-resolution imaging support to UWCCC members who
utilize small animal models in their research. The Faculty Leader and Facility Manager provide guidance to
investigators ensuring the imaging modality and experimental design are best suited to address their cancer
question. Incorporating positron emission/computed tomography (PET/CT), magnetic resonance imaging (MRI),
ultrasound (US), photoacoustics, and/or optical bioluminescence/fluorescence/near-infrared (NIR) imaging
modalities, the SAIF affords access to all major small animal imaging modalities. Moreover, UWCCC
investigators can select their desired level of service deliverables ranging from image acquisition, reconstruction,
and interpretation to analysis, and/or presentation slide preparation. When necessary, commercial or proprietary
imaging agents are acquired for investigators and their quality ensured prior to use. The SAIF holds umbrella
animal use, biosafety, and radiation safety protocols thus assuring appropriate regulatory control of imaging
studies while minimizing the regulatory burden placed on individual investigators. Located adjacent to similar
clinical research scanners, the SAIF strives to design preclinical imaging assessment of new imaging agents
with eventual clinical translation in mind. One such agent, CLR1404, underwent extensive preclinical evaluation
within the SAIF prior to translating into 8 clinical imaging and radiotherapy trials. During the current CCSG funding
cycle, the SAIF has provided critical imaging support to 65 unique UWCCC members representing all six
UWCCC programs. We continue to assess new imaging and related technologies and, if suitable and relevant
to the membership, develop a plan to bring such new technologies into the facility. Our specific aims are to; 1)
provide UWCCC members seamless access and guidance to the most advanced small animal cancer imaging
technologies for essential preclinical assessment of new therapies; and 2) to provide preclinical discovery and
development support for new molecular imaging and diapeutic agents. Funding provided from the CCSG is
critical in supporting our mission to serve the UWCCC membership at the highest level possible while minimizing
costs in a relatively expensive technology-centric field. We expect that our role in the development and evaluation
of new imaging and therapy agents, especially those being developed by our own membership, as well as the
assessment of new therapeutic agents via imaging, will ultimately permit personalized treatment planning and
improve the quality of life and survival outcomes of cancer patients.